Novel Lymphocyte Chemoattractant Receptor and Ligand

PROJECT SUMMARY/ABSTRACT
The immune system at mucosal sites has evolved to mediate rapid immunity to invading pathogens, while
limiting over-reactive responses that drive chronic inflammation. Mechanisms of lymphocyte trafficking are
essential for the function and systemic integration of the immune system, and in particular for targeting immune
responses to specific mucosal and epithelial organs and tissues in the body. Despite identification of trafficking
receptors for the small intestines, colon, and skin, we have limited knowledge of mechanisms of lymphocyte
recruitment to the lung and to most non-intestinal mucosal sites. Defining mechanisms controlling organotypic
lymphocyte homing to these tissues which will be critical for developing therapies to control immune
pathologies.
We have identified a novel lymphocyte chemoattractant receptor and its chemoattractant ligand,
selectively expressed in lung, airways, upper GI tract, genitourinary mucosae and mucosa-associated glands
including the pancreas and salivary glands. Under Aim 1 we will mechanistically probe the receptor-ligand
interactions focusing on the specificity and signaling pathways activated by the novel receptor and its role as a
lymphocyte vs myeloid cell chemotactic receptor. Structure-function studies will identify ligand domains for
receptor binding and activation. Aim 2 will define the regulation of the receptor in the mouse, and its role in
lymphocyte population of and homing to non-lymphoid tissues during homeostasis and in the setting of chronic
multi-organ autoimmune inflammation. The roles of the pathway in immune cell development will be probed in
mixed bone marrow chimeras in which receptor-deficient vs wild type stem cells compete for reconstitution of
immune compartments in lymphoid and non-lymphoid tissues. Aim 3 will elucidate the tissue- and cell subset-
specific expression of the receptor and ligand in humans. Regulation of the receptor will be studied in
organotypic lymphocyte development and activation, in homeostasis, and in pulmonary immune challenge and
infection. We will employ innovative approaches and develop new tools to address the fundamental role of
the novel pathway in the immune system, and where possible, translate our findings from mice into humans.
Results from these studies will significantly advance our understanding of the systemic organization and
integration of the mucosal immune system. The mechanisms identified will provide the basis for new
approaches to manipulating immunity and inflammation in the lungs and extraintestinal mucosae.

Public health relevance
PROJECT NARRATIVE Lymphocytes migrate from the blood into the various tissues of the body where they provide immunity to infection and control cancer, but can also cause autoimmune and other inflammation associated diseases. The focus of this application is on newly discovered mechanisms that control lymphocyte access to some of the most clinically important organs in the body...including the lungs and airways, stomach, genitourinary tract and the pancreas. The proposed studies could lead to improved vaccine strategies and to novel preventative, therapeutic or curative treatment strategies for autoimmune, inflammatory, and neoplastic diseases.